Summer Research Program (SRP) (I01)

Veterans Affairs Caribbean Healthcare System (VACHS) strives for excellence in research and patient care.
Mentoring and research training in early professional career plays an important role in instilling scientific
interest in future healthcare professionals. Nationally, Hispanics/Latinos are underrepresented in research and
science, technology, engineering, and mathematics (STEM) disciplines. Puerto Ricans, also Hispanics/Latinos,
have other factors that makes research mentoring extremely difficult such as lack of resources and expertise to
pass on the knowledge and opportunities, among others. This translates to a less than optimal and lack of
research driven care for patients in the island. VACHS is no exception to this, thus the great importance to create
innovative and comprehensive mentoring program catered to the needs of both the future professionals and the
Veterans that will benefit from it. The proposal aims to create a two-track mentoring program that targets
students at different career levels, from undergraduate to graduate and professionals. One of the tracks is focused
on clinical and translational research suitable for undergraduates and medical students, while the second track
is tailored for students with or enrolled in a master program of public health or biostatistics. The proposed
program is the only one in its class offered in the island, thus offering an immeasurable impact in the participants.
One of the most important aspects of creating a funded program is that it gives the opportunity to local students
that otherwise cannot afford to participate of such program due to them being under the poverty line. Providing
stipend and housing eliminates the financial burden some participants might have and encourage their
participation. The participants selected to take part in the program will have a one-to-one mentoring experience
for the 12-week program duration and will be involved in a research project. In addition to the mentoring aspect,
the participants will take part in a comprehensive didactive curriculum that aims to give them all the knowledge
needed to perform successful research within VA. Since VACHS also aims to aid in the participants career
formation and to ensure their success overall, there are some lectures and seminars that cover career
development aspects. Another unique and important activity VACHS summer research mentoring program
offers is a travel experience to NIH. This travel experience offers the opportunity to the participants to interact
with underrepresented minority principal investigators that work at NIH, and they also get to learn about
translational research. Another unique experience that VACHS summer research program offers is to participate
is a novel workshop called The Hack-a-Thon. The Hack-a-Thon is a workshop where participants from two
different VA Summer research programs, at different institutions, work in a big data project together. This
activity aims to create a professional collaborative network where the participants learn how to divide tasks, work
together towards the same goal, and leadership skills in a hands-on workshop. Once the participants culminate
their 12-week commitment with the program they are offered the opportunity to stay working as without
compensation appointees to keep contributing to their research project; therefore, offering a unique opportunity
to experience firsthand work within VACHS, see the result and effect of their respective clinical studies, and
envision themselves as working professionals in the system.

Public health relevance
The main goal of the proposed project is to instill early research knowledge in healthcare professionals by providing mentoring and exposure to clinical research. The program offers a series of courses, experiences, and involvement in research projects aimed to better the Veterans’ care. The population in the Caribbean US territories is isolated from that of the contiguous US geographical areas hindering the optimal preparation of future physicians and the continuous application of the latest research guided medicine approaches to improve healthcare. Offering summer research programs within VA, that immerse the students in clinical research early in their careers, allows for more research educated physicians translating to up-to-date and innovative care for the Veterans. The program gives the opportunity to learn more about VA, its mission, and how their future career as physicians and scientists can contribute to improve Veterans’ care.